DHEA EFFECTS ON MOOD &MEMORY IN HEALTHY HUMANS

The aim of this study is to investigate the cognitive, affective, and medical effects of restoring circulating levels of DHEA to approximately the high-normal range of young adults in psychiatrically and medically healthy men and women between the ages of 56 and 85 years whose serum DHEA-S levels are in the lower 50% for their age group. The study is a double-blind, crossover, administration trial. Subjects will receive placebo or DHEA (45 or 90 mg) for six months, no drug for one month, and the other treatment (DHEA or placebo) for six months. At the beginning and end of each six-month administration period, subjects will undergo mood and memory assessments, a blood draw, and a variety of medical tests. We hope to use the GCRC for the following procedures: phlebotomy, urine sample collection, analysis of urinary bone products, subject instruction in maintaining a food-choice diary, provision of standard meals, and possibly other medical tests or subject instructions.